Systematic Analysis of the Actin Cytoskeleton and Directed Cell Migration

PROJECT ABSTRACT
Cell motility is one of the oldest problems in cell biology as the movement of cells was one of the first things
noted when the microscope was developed in the 17th century. The last sixty years of work revealed that the
molecular underpinnings of motility involve the active control of the cytoskeleton. However, many questions
remain unanswered. While we have identified many of the components of the cytoskeleton and know a great
deal about their biochemical and structural characteristics, we lack a systematic understanding of how the parts
interact to produce coordinated cytoskeletal function such as during cell migration. Perhaps the most important
problem in cell motility is understanding how cells perceive various cues in their environment and convert this
information into a directed migration response. A deeper understanding of these two inter-related problems will
inform higher order biological processes such as embryogenesis, immune response, and wound healing, as well
as diseases states such as metastatic cancer. This proposal seeks to extend our work in this area with the
renewal of our R35/MIRA grant, R35 GM130312. Using a conditional knockout mouse model where the gene
encoding the critical Arpc2 (p34) subunit of Arp2/3 can be deleted on command, we have been dissecting the
systematic relationship between Arp2/3-branched actin and non-branched actin in several cellular processes.
Our published and preliminary data indicate that the migration substrate has a profound influence on the
architecture of branched actin at the leading edge of migrating cells. Furthermore, unpublished proteomic data
demonstrate that a tyrosine kinase pathway controlling clathrin-mediated endocytosis is mis-regulated in the
absence of Arp2/3. Building on these observations, we propose to study the role of integrin-based cell adhesion
on Arp2/3-branched actin regulation and the regulatory network that controls the balance between clathrin pits
and flat clathrin lattices. On the question of directed migration, we propose to build on our recently published
durotaxis assay to understand the relationship between cell-generated traction force, cell shape and directed
whole cell movement. Finally, we propose to use our expertise in cellular optogenetics to develop an optotaxis
assay to direct the migration of cell with gradients of light and test the role of polarized signaling pathways in
controlling actin architecture, cell shape and directed migration.

Public health relevance
PROJECT NARATIVE Cell migration is essential for many physiological processes such as wound healing, immune response, and morphogenesis, and plays a significant role in pathological processes such as cancer metastasis and cardiovascular disease, the two leading causes of death in the developed world. We propose to study cell migration using a multi-disciplinary approach involving molecular perturbations, cutting-edge microscopy and image analysis. These studies will directly contribute to understanding of disease states such as tumor metastasis, fibrosis, and cardiovascular disease, and to our understanding of normal physiological processes such as wound repair.